POLYCYCLIC AROMATIC HYDROCARBONS: ULTRASENSITIVE DETECTION,EARLY LIFE EXPOSURES-CLINICAL OUTCOMES (PRETERM BIRTHS, CHRONICLUNG DISEASE, AND NEUROCOGNITIVE DEFICITS), PREVENTION ANDREMEDIATION

Project Summary
The preterm birth (PTB) rate in Harris County, which includes Houston, TX (the 4th largest
city in the US), is an alarming 12.1 % (national average in US is 9.6%). The over-arching
hypothesis of the BCM-Rice SRP is that maternal exposure to polycyclic aromatic hydrocarbons
(PAHs) emanating from superfund sites, as well as other environmental chemicals, increases the
risk of PTBs and augments major neonatal morbidities such as BPD. The Specific Aims of the
overall center are:. The overall goal of project 1 is to develop new and innovative approaches
[Surface-Enhanced Raman and Infrared Absorption Spectroscopies (SERS and SEIRA)],
combined with Machine Learning (ML) that enable the rapid, streamlined analysis of soil, water,
and air samples for the presence of PAHs. 2. To test the hypothesis that exposures to PAHs at
Superfund sites are major PTB risk factors, and that placental epigenome alterations contribute
to PTB (biomedical project 2).. Furthermore, we will test the hypothesis that the aryl hydrocarbon
receptor (AHR) and cytochrome P450 (CYP)1A/1B1 enzymes play a key role in PAH-mediated
neonatal lung injury in mice (project 3). 3 To test the hypothesis that pyrolytic treatment of
contaminated soils under carefully selected conditions will reliably achieve regulatory
compliance and eliminate toxicity while recovering soil fertility to facilitate ecosystem
restoration (project 4). 4. To develop innovative strategies to prevent and reduce the public health
burden associated with PAHs and other hazardous chemicals present in Superfund sites
[Community Engagement Core (CEC) (Core B)], and develop partnerships with primary
stakeholders (i.e. EPA, ATSDR, TCEQ), communicate with NIEHS, and foster collaborations
within the SRP, with sister SRP centers, and develop technology transfer [Administrative Core
(AC) (Core A)]. 5. To train students and postdoctoral fellows in a cross-disciplinary manner, so
that the next generation scientists, engineers, and physicians will make fundamental contributions
to Environmental Health [Research Experience and Training Coordination Core (RETCC) (Core
C)]. 6. To seek support of Research Support Cores that will be a central resource for multi-omics
and chemical studies (Projects 1-4), and to support the management and integration of assets
across all the projects and cores of the center via the Data Management and Analysis core
(DMAC/Core F). Thus, this SRP uses a systems approach that integrates environmental science
research, biomedical research projects, and cores to determine the mechanisms by which PAHs
contribute to PTBs. and understand the factors could be targets for interventions to prevent and
reduce the health burden associated with PAHs present in Superfund sites.

Public health relevance
Project Narrative: The preterm birth rate in Harris County, Houston, TX is an alarming 12.1% (national average in US is 9.6%), and in areas surrounding the superfund sites, the preterm birth (PTB) rate is even higher (> 20%). The overarching goal of the Baylor-Rice Superfund Research Program (SRP) is to that maternal exposure to polycyclic aromatic hydrocarbons (PAHs), which are present in superfund sites, increases the risk of PTBs and incrementally augments major morbidities such as chronic lung disease [bronchopulmonary dysplasia (BPD] in premature infants. These studies proposed here should lead to reduction of health burden associated with PAHs in Superfund sites, and should also help in risk assessment strategies by partnering with EPA, ARSDR, TCEQ, etc.